T Lymphopenia in Ischemic Heart Failure

Myocardial infarction (MI)-induced heart failure is the leading cause of morbidity and mortality in the United
States. About one in four MI patients will progress to develop chronic heart failure, which has a 5-year mortality
rate of 40%. It is highly urgent to improve long-term outcomes of MI patients. Lymphopenia, a reduction in
peripheral blood lymphocyte count (primarily due to T-cell loss), has consistently been shown to correlate with
worse cardiac function and poor outcome in MI patients and is an independent marker to predict the prognosis.
Unfortunately, how T lymphopenia occurs following MI and whether targeting T lymphopenia has therapeutic
potential are largely unknown. Using the mouse MI-induced ischemic heart failure model, our preliminary data
showed that MI-induced T lymphopenia may involve blood T-cell redistribution to the bone marrow and T cell
development impairment. CD4+ T-cell activation is known to improve wound healing post-MI. Thus, persistent
CD4+ T lymphopenia may reduce protective CD4+ T-cell response and compromise myocardial repair after MI.
The goals of this proposal are: 1) to elucidate the underlying mechanisms that cause T lymphopenia following
MI; and 2) to investigate whether inhibiting CD4+ T lymphopenia can serve as a therapeutic strategy. We
hypothesize that MI induces T lymphopenia by both stimulating T-cell trafficking from blood to the bone marrow
and impairing T lymphopoiesis; inhibiting CD4+ T lymphopenia improves post-MI cardiac repair. Three specific
aims will address this novel hypothesis in a mouse ischemic heart failure model that combines multidisciplinary
approaches. Specific Aim 1 will examine the mechanisms of blood T-cell trafficking to the bone marrow and
alterations of distinct T-cell phenotypes and functions after MI. Specific Aim 2 will determine the mechanisms by
which MI impairs T lymphopoiesis. Specific Aim 3 will examine the hypothesis that inhibiting CD4+ T lymphopenia
would improve post-MI cardiac repair. Accomplishment of this proposal will provide new insights into T
lymphopenia mechanisms in ischemic heart failure and may offer potential intervention strategies to improve the
prognosis of heart failure patients.

Public health relevance
PROJECT NARRATIVE Over one million Americans each year are diagnosed with myocardial infarction (MI), of which around 25% will continue to remodel and develop chronic heart failure. The goals of this proposal are to elucidate the molecular mechanisms that cause post-MI T lymphopenia (a decrease in peripheral blood T-cell count) and to investigate whether preventing CD4+ T lymphopenia can serve as a therapeutic strategy. Accomplishment of this proposal will likely provide a potential intervention strategy to improve cardiac repair in ischemic heart failure.